Latino School Readiness: Engaging Pediatric and Early Childhood Systems to Adapt and Pilot Family Centered Primary Care Interventions

PROJECT SUMMARY
Children who enter school ready to learn are more likely to succeed academically. Yet, low-income children
often enter school behind their more affluent peers. The growing population of Latino children experience
economic and cultural barriers to school readiness (SR). The primary care clinic represents an opportunity to
augment the fractured early childhood education (ECE) system, as pediatricians have trusted, repeated
relationships with children and families. In prior work Latino families of recent kindergarteners identified specific
interventions that could be adapted to their needs in the pediatric clinic including increased knowledge through
skills checklists and text messages, connection to preschool through automatic referrals and parent
empowerment through coaching with parent-child dyads.
My long-term goal is to be an independent physician-scientist and leader in development and implementation
of SR supports for Latino children. This K08 grant will provide mentorship and skill development in learning
health systems to become a school readiness expert and prepare for an early career award. My career
development plan includes specific training goals: 1) expertise in mobile health interventions, 2) advanced
implementation science, 3) clinical trial design for multi-component interventions, and 4) history and
educational culture of immigrant Latinos in the US.
The research objective of this K08 Career Development Proposal is to refine and pilot test a package of parent
preferred pediatric clinic-based SR interventions that specifically target the SR needs and desires of Latino
families. The study premise is that the pediatric clinic is a trusted, acceptable and feasible setting to identify
and address SR needs. Specific Aims: (1) qualitatively determine acceptability, perceived benefits and
implementation for a package of primary-care based SR interventions through interviews with pediatric
providers and early childhood educators (ECE) (n=20), (2) engage a stakeholder panel to prioritize usable and
acceptable SR interventions, create a SR program for the clinical setting, and develop an implementation
strategy for pilot testing and 3) pilot the SR intervention program with parents of Spanish speaking first-born 2-
3-year-olds to determine feasibility and acceptability in the primary care clinic (n=50).

Public health relevance
PROJECT NARRATIVE Developing culturally responsive, acceptable and feasible interventions to promote school readiness is key to reducing the disparities that exist in educational attainment of Latino children living in poverty. The studies described will develop and pilot test a school readiness program based in primary care for Spanish speaking parent-child dyads that is centered on the preferences of Latino parents, their pediatric providers and early childhood educators.